Antiparasitic Agent Discovery from Natural Products for the Treatment of a Globally Emerging Disease

PROJECT SUMMARY/ABSTRACT
Hawaii leads the nation in reported cases of human angiostrongyliasis, or rat lungworm (RLW) disease, a
potentially lethal central nervous system infection caused by the parasitic nematode Angiostrongylus
cantonensis. Anthelmintics specifically targeting A. cantonensis are not available. Thus, an urgent need
exists to develop effective drugs for this emerging and neglected tropical disease. Natural products are the
best source of drug leads for parasitic diseases, as previously demonstrated for parasitic diseases, such
as artemisinin for malaria, Ivermectin for river blindness and lymphatic filariasis. Our long-term goal is to
identify novel anthelmintic natural products from microorganisms including under-explored Hawaiian fungi
and bacteria. The objective of the proposed research is to discover natural products that immobilize
infectious third stage A. cantonensis larvae (L3). Our central hypothesis is that natural products such as
the under-explored endophytic fungi in Hawaii and other microorganisms are a rich source for anti-A.
cantonensis natural product drug discovery. The rationale of the proposed research is that once novel
potent anti-RLW natural products are identified, lead compounds will be studied for their mechanisms of
action and tested in vivo in the near future. The objectives of this project will be accomplished by two
specific aims: (1) Screen NPs against infectious A. cantonensis L3; (2) Identify and characterize motility
inhibiting and viability reducing bioactive NPs via assay-guided separation and structure elucidation, and
assess Blood-brain barrier (BBB) permeability and efficacy. This study is innovative because it: (a) uses
our newly established high-throughput screening (HTS) assay to screen our new and unique natural
product library (NPL) against RLW; and (b) utilizes a new infrared-based motility-inhibition bioassay to
screen fractions from our NPL against infectious L3 larvae. The proposed project is significant because it
aims to reduce human suffering from emerging infectious diseases through the development of effective
therapeutics, and will strengthen the research infrastructure for natural product drug discovery and
molecular medicine in Hawaii. Our approach could serve as a model for carrying out natural product drug
discovery against other newly emerging parasitic diseases. This project will also provide research
experience opportunities for graduate students and ethnically diverse and socioeconomically
disadvantaged undergraduate students in the state of Hawaii.

Public health relevance
PROJECT NARRATIVE - PUBLIC HEALTH RELEVANCE STATEMENT Neuroangiostrongyliasis is a potentially lethal central nervous system parasitic infectious disease occurring in high incidence in Hawaii and other Pacific Islands, and is emerging in other tropical and subtropical regions, including significantly the southeastern US. However, there is no specific treatment for the disease. Thus, the proposed project has immense public health importance to the state of Hawaii and is of immediate relevance to the Asia-Pacific region, as well as the continental United States, where the range of A. cantonensis is expanding.